Evaluations of medication assisted treatments for substance use disorders among persons living with and at risk for HIV infection

Project Abstract:
This is an application for a renewal of a fiver-year Independent Scientist Award (K02) to assist in the continued
protected time to allow Dr. Sandra Springer to continue her productive research career involving interventions
that will improve integration of HIV and substance use disorder (SUD) treatment among persons living with HIV
(PLH) and those at risk for HIV infection. This award will also increase her time to devote towards mentoring
young investigators who share this interest. The prevalence of HIV infection is 28 to at least 50 times higher
among people who inject drugs (PWID) compared to the general population. In North America, there were an
estimated 267,000 persons living with HIV infection (PLHs) among 2 million PWIDs in 2012. Opioids represent
the dominant class of injected agent, and in 2013 517,000 adults reported heroin use within the past year,
representing an approximately 150% increase compared to 2007. Medication-assisted treatment (MAT) for
opiate addiction, combined with needle and syringe exchange programs (NESP) have substantially reduced
the risk of HIV transmission in PWIDs. Moreover, MAT reduces mortality among HIV-positive PWIDs (which is
otherwise 3-fold higher than in PWIDs who are HIV-negative). MAT is predominantly available in the form of
opioid agonist treatment with methadone or buprenorphine, with emerging use of opioid antagonist treatments
(e.g. extended-release naltrexone). However, there are no recommendations currently available to guide the
selection of MAT agent. Moreover, despite substantial evidence for immunomodulatory effects of opioids on
immune responses, no studies have employed systems biology methods to evaluate MAT agents for their
effects on parameters such as chronic inflammation—particularly important for HIV disease progression and
present even in elite controllers or individuals who have achieved virologic control without antiretroviral therapy
(ART). To address these questions, Dr. Springer has been awarded a NIDA funded 5 year R01 to evaluate
innate immunity and inflammation with her co-PI at Yale School of Medicine, Dr. Shaw, to carry out a
prospective, longitudinal study of HIV-positive (on ART) vs. HIV-negative PWIDs starting MAT, recruited from
the largest drug treatment center in New Haven, Connecticut. The strength of this proposal is that Dr. Springer
is: (1) experienced in HIV and Addiction Medicine; (2) experienced in the novel use of pharmacologic
interventions (MAT) to treat SUDs to prevent relapse to opioid and alcohol use as a means to improve HIV viral
suppression; (3) has over 15 years experience of conducting NIH-funded research among PLH with SUD and
using MAT interventions; and (4) is a co-PI on a successful R01 affiliated with this application that is extending
her experience with using systems biology to evaluate MAT on chronic inflammation of HIV infection. As such,
the individual, our health care system and society have a high likelihood to benefit – especially on the reduction
of HIV within the community.

Public health relevance
Project Narrative This renewal application for an Independent Investigator K02 award will assist Dr. Springer in continued productive scholarship and increased mentorship of young investigators regarding research involving interventions that will assist in the integrated treatment of persons living with HIV (PLH) and at risk for HIV infection with co-occurring substance use disorders (SUDs) using medication assisted therapies (MAT). Using state of the art systems biology, Dr. Springer with colleagues proposes to study the cellular, gene expression, and biochemical responses to opioid addiction treatment in a group of HIV-positive, compared to HIV-negative adults beginning MAT as her primary affiliated project with this award. She also plans to continue to produce research proposals that will evaluate MAT as HIV prevention in persons with SUDs who are at risk of acquiring HIV and to improve HIV treatment outcomes among those living with HIV. 1